Novel Telomere-Targeting Therapy for Advanced Non-Small Cell Lung Cancer

Summary: With non-small cell lung cancer (NSCLC) persisting as a leading cause of cancer mortality worldwide
and resistant to many standard treatments, MAIA Biotechnology, Inc. is focused on developing THIO, a novel
therapeutic agent aimed at improving treatment outcomes in patients with advanced-stage NSCLC. THIO, a
direct telomere targeting agent, is designed to exploit the vulnerability of cancer cells’ telomerase-dependency,
offering a new avenue for therapeutic intervention in cases where existing options fail. To address the limited
efficacy and resistance issues associated with current NSCLC treatments, our objective is to evaluate the safety
and efficacy of THIO in combination with the immune checkpoint inhibitor cemiplimab in a multicenter, open-
label, single-arm Phase 2 clinical study. The study will enroll subjects with stage 3 or 4 NSCLC who have shown
resistance to prior checkpoint inhibitors, utilizing THIO's mechanism of causing tumor cell death by incorporation
into telomeres and inducing instability. This Phase 2 clinical trial follows promising preclinical and early clinical
results where THIO showed high selectivity in killing telomerase-active cancer cells and significant synergy with
immune checkpoint inhibitors. Given the high incidence of NSCLC and the significant portion of patients lacking
effective treatment options, the successful development of THIO could dramatically enhance quality of life and
survival rates by providing a new, effective treatment modality. This project not only addresses an urgent public
health need but also advances our understanding of cancer biology and treatment, potentially offering broader
implications for other telomerase-positive cancers.

Public health relevance
Narrative: The project aims to address the unmet need for effective treatments in advanced non-small cell lung cancer (NSCLC), a prevalent and lethal form of cancer. By developing our novel drug candidate, THIO, in com- bination with cemiplimab, this study explores a novel therapeutic approach targeting telomere dysfunctions in cancer cells, which could lead to significant advances in treatment effectiveness and patient outcomes. If suc- cessful, this research will contribute to fundamental knowledge about cancer mechanisms and offer a new solu- tion to enhance health, lengthen life, and reduce disability and death as a third-line treatment for NSCLC.